Cancer Center Administration

ABSTRACT, Administration
The Indiana University Melvin and Bren Simon Cancer Center (IUSCC) is a distinct organizational unit within the
IU School of Medicine. IUSCC administration works closely with the various units of the school including
Finance, Human Resources, Information Technology, Strategic Communication, Research Administration, and
the Office of Clinical Research. Administration provides infrastructure support including finance, pre- and post-
award of grants and contracts, financial management of shared resources, capital equipment procurement,
maintenance of common equipment in IUSCC space, internal and external communication and support of the
IUSCC pilot project program. The major functions of the IUSCC Administration are: to coordinate strategic
planning; to stimulate and support transdisciplinary Research Programs; and to provide administrative and
financial oversight for the Shared Resource facilities, including the Clinical Trials Office (CTO). In addition,
IUSCC Administration is responsible for providing support in the following key areas: pre- and post-award
management for grants and contracts; financial management of university and foundation accounts;
development and maintenance of the IUSCC webpages and databases; coordination of communication to
IUSCC members; information technology support for members, staff and shared resources; and human resource
management of IUSCC staff. Administration supports Research Programs through coordination of monthly
seminars and working group meetings, yearly retreats, pilot project announcements, administration of the IUSCC
Translational Research Acceleration Collaboration (ITRAC) process, dissemination of external funding
announcements, and coordination of the IUSCC Seminar Series. The IUSCC budget in FY 2018 was $27.7M,
including $2.18M from the CCSG (8%). IUSCC supports 142 programmatically aligned members from
nine schools and 42 Departments.